Squirrel Monkey Breeding and Research Resource

PROJECT SUMMARY: OVERALL COMPONENT
This application is a competing renewal of the “Squirrel Monkey Breeding and Research Resource”
(SMBRR) P40 OD010938 which has received continuous NIH grant support since 1980. The SMBRR is the
only national research resource of squirrel monkeys available to NIH grantees, intramural research
programs of federal agencies including the FDA, NSF, and the NIH, and other sponsors of biomedical
research (private foundations, pharmaceutical companies, and contract research organizations). Because
Bolivian squirrel monkeys are no longer available from source countries, and there are no other breeding
colonies of pedigreed squirrel monkeys available for biomedical research, the SMBRR is a unique
research resource that cannot be duplicated or replaced. The scarcity of squirrel monkeys,
difficulties associated with captive breeding, as well as the challenges associated with their care and use in
research, all contribute to the need for this nationalresearch resource. The SMBRR has integrated multiple
disciplines into a program designed to meet the needs of investigators who utilize its resources. In the
upcoming years, the SMBRR will continue to improve the resources it provides and continue to add new
information about the biology and research value of squirrel monkeys. Squirrel monkeys continue to be an
important animal model in neuroscience research, drug addiction research, malaria vaccine research, and
fundamental evolutionary biology. Over the next five years,the SMBRR will focus on refining the
animals and related resources to meet the needs of the scientific community. The aims of the
Resource Core Component address our continued commitment to meeting the needs of the research
community for access to squirrel monkeys and information about using squirrel monkeysin research. We will
explore the causes of perinatal mortality in a retrospective epidemiology study as well as the potential role of
different genes. We will expand our biobanking program to prioritize collection of frozen and formalin-fixed
tissued for use in molecular biological and gene expression studies (both bulk and single nuclei approaches).
The Applied Component research projects focus on basic research projects that will enhance to use of the
SMBRR and provide data on best practices and uses of different anesthetics on brain and behavior. The
Curation and Informatics Component is designed to simplify access to SMBRR materials by the scientific
community and to facilitate accurate documentation of its use. The overall goals of the SMBRR are to
provide a national research resource of squirrel monkeys; provide squirrel monkey derived
biological materials; provide education and training opportunities to scientists wishing to
workwith squirrel monkeys, colony managers, and animal caregivers; and provide
investigators with facilities and expertise to conduct studies using squirrel monkeys.

Public health relevance
PROJECT NARRATIVE: OVERALL COMPONENT The “Squirrel Monkey Breeding and Research Resource” (SMBRR) maintains the only self- sustainingnational research resource of laboratory-born squirrel monkeys, their tissues and other biological materials, as well as the expertise to carry out research on this important research animal. Scientists withNIH grants utilize squirrel monkeys to study many diseases that threaten human health including Alzheimer’s disease and other disorders of the central nervous system, drug addiction, malaria, and viral diseases.